Amygdala pain mechanisms

Project Summary
Chronic pain, a complex multidimensional disorder, remains a major health care issue and a therapeutic challenge. The
development of new and improved therapeutic strategies requires the full understanding of mechanisms of chronic pain
at all levels of the neuraxis and for all cell types, including non-neuronal elements. Neuroimmune signaling has emerged
as a peripheral and spinal pain mechanism, but little is known about the role, regulation and therapeutic potential of
molecular crosstalk between neuronal and glial cell types in the brain in the context of pain. To address this important
knowledge gap we will build on our NIH-funded work (since 1999) that impacted the field by identifying neuroplasticity
in the amygdala, a brain center for emotions, as a critical mechanism for emotional-affective aspects of pain and pain
modulation. The proposed project will test the novel hypothesis that chronification of amygdala plasticity and
neuropathic pain behaviors depends on a cascade of neuroimmune signaling that can be targeted to mitigate
neuropathic pain. Specifically, enhanced synaptic drive of certain amygdala neuron types at the acute pain stage
activates different types of glia, and glia-derived factors generate hyperexcitability in distinct amygdala neuron types at
the chronic stage to maintain neuropathic pain. A comprehensive multidisciplinary approach will be used that
integrates state-of-the-art transcriptomics, bioinformatics, behavioral assays, brain slice electrophysiology,
pharmacology, chemogenetics, optogenetics, viral vector strategies, immunohistochemistry and molecular biology for
the analysis of neuroimmune interactions within and between different types of neuronal and glial cells in the amygdala
output region (central nucleus, CeA) in the well-established spinal nerve ligation (SNL) rat model of neuropathic pain.
Male and female rats will be studied. A transgenic Crh-Cre rat model will be used to study the CeA corticotropin
releasing factor (CRF) system, an important player in amygdala plasticity, and its role in neuroimmune signaling. Aim 1
will use a combination of cell-specific bulk and single-cell RNA sequencing (scRNA-Seq) to identify individual genes,
molecular pathways and functional cellular states associated with pain chronification. A novel computational scRNA-Seq-
based interactome analysis will determine neuron-glia interactions at the acute and chronic stages of neuropathic pain
and identify drug-targetable molecular factors. Aim 2 will determine the behavioral significance of neuron-glia-neuron
signaling in the CeA at different stages of neuropathic pain, using chemogenetic activation and inhibition of different cell
types and pharmacological (or viral based) tools to modulate molecular factors. Sensory thresholds, emotional
responses, non-evoked ongoing pain, and anxiety- and depression-like behaviors will be measured. Aim 3 will determine
electrophysiological mechanisms of neuron-glia-neuron signaling in the CeA at different stages of neuropathic pain,
using patch-clamp recordings of different cell types in brain slices and chemogenetic and pharmacological (or viral
based) manipulations. Successful completion of these conceptually innovative studies will significantly advance our
knowledge of neuro-immune signaling in brain plasticity and in the transition from acute to chronic pain and provide
novel targets to mitigate chronic neuropathic pain.

Public health relevance
Public Health Relevance Statement (Project Narrative) Chronic pain is a major health care issue, but mechanisms of the transition from acute to chronic pain still remain to be determined, particularly at the level of the brain. The proposed multidisciplinary research project addresses this important knowledge gap by identifying neuro-immune signaling in the amygdala, a brain center for emotions and pain modulation, as an important pain mechanism. Successful completion of the proposed studies will advance our knowledge about neuro-immune brain mechanisms of pain that can be targeted for pain management, which is highly significant from a basic science and clinical perspective hence translational.